Regulation of Cardiac Adrenergic Function by S-nitrosylation

DESCRIPTION (provided by applicant): Accumulating evidence indicates that nitric oxide (NO), through S-nitrosylation of Cys residues within multiple, functionally interrelated signaling elements, regulates agonist-induced desensitization and internalization of β- adrenergic receptors (β-ARs). We have demonstrated that NO synthases and the endogenous S-nitrosothiol (SNO), S-nitrosoglutathione, preserve cardiac contractility and prevent down-regulation of β-ARs during maintained agonist stimulation. These effects of NO/SNO on β-AR signaling and trafficking, which can be recapitulated in cellular systems, appear to be mediated, in significant part, by S-nitrosylation of the G protein- coupled receptor (GPCR) kinase, GRK2. Additional components of the β-AR system are also regulated by S- nitrosylation, which suggests a broad functional role for NO/SNO, exerted through targeted S-nitrosylation. In particular, we have recently identified the β-arrestins (βarr1 and βarr2) as targets of β-AR-coupled S- nitrosylation by NO synthases (eNOS and nNOS). S-nitrosylation of βarr2 by eNOS at a single critical site (Cys 410) regulates its protein-protein interactions with clathrin and adapter protein-2 (AP-2) in vitro and in vivo, thereby promoting agonist-mediated β2-AR internalization. However, differential regulation of βarr1 and βarr2 by S-nitrosylation and the consequences of these modifications for cardiac function have not been explored. Our central hypothesis is that S-nitrosylation of the β-arrestins will provide a basis for control by NO of β-AR trafficking and signaling, with important ramifications in healthy and failing hearts. Moreover, we predict that the regulation of βarr1- and βarr2-specific interactomes by S-nitrosylation will provide a principal mechanism through which NO exerts its regulatory influence. We will carry out the following specific aims: 1. Elucidate the sites of agonist-dependent S-nitrosylation of the β-arrestins by eNOS and nNOS in cells and tissues;2. Elucidate the consequences of β-arrestin S-nitrosylation for β-AR internalization and desensitization;3. Assess the consequences of β-arrestin S-nitrosylation for β-AR-dependent signaling;and 4. Assess the functional roles of β-arrestin S-nitrosylation in the intact heart. Collectively, these studies should provide fundamental and novel insights into β-AR regulation by NO in both healthy and failing hearts and may open a new area of research. PUBLIC HEALTH RELEVANCE: Heart failure is associated with both attenuated β-adrenergic receptor (β-AR) signaling and decreased nitric oxide (NO) bioavailability. Because NO acts through S-nitrosylation to regulate both β-AR densitization and downregulation, understanding the mechanisms of action of S-nitrosylation in β-AR signaling and trafficking may improve understanding of β-AR dysfunction and suggest novel therapeutic approaches to heart failure.

Public health relevance
Relevance to Public Health Heart failure is associated with both attenuated β-adrenergic receptor (β-AR ) signaling and decreased nitric oxide (NO) bioavailability. Because NO acts through S-nitrosylation to regulate both β-AR densitization and downregulation, understanding the mechanisms of action of S-nitrosylation in β-AR signaling and trafficking may improve understanding of β-AR dysfunction and suggest novel therapeutic approaches to heart failure.